Harnessing Diverse Bioinformatic Approaches To Repurpose Drugs For Alzheimers Disease And Related Dementias

Abstract
The exploration of genomes, transcriptomes, and proteomes derived from brains with Alzheimer's disease
(AD) by powerful computational tools has developed new knowledge, including the identification of pathways
and targets that may be involved in the initiation and/or progression of the disease. The challenge is to find
drugs that impact those pathways and then validate the importance of those pathways – distinguishing primary
disease drivers from secondary events. Repurposing FDA-approved drugs is one approach to probe
potential pathways in proof of concept, and ultimately therapeutic, clinical trials. In this renewal application, we
propose to discover and validate hypotheses for Drug Repurposing In AD (DRIAD) through three integrated,
complementary informatics approaches. Specifically, we will extend our systems pharmacology (DRIAD-SP)
tool of classical and network aware (prior-loaded) machine learning approaches to identify pathways and
targets altered in AD brains at different stages of disease progression using data from Accelerating Medicines
Partnership-AD available through Synapse (Aim 1); we will use chemical biology and systems pharmacology
approaches to discover the target selectivity of lead kinase inhibitors within human neuronal and glial cell types
using unbiased RNA-seq, proteomic and imaging studies followed by pathway analysis (Aim 2). We will
implement additional causal inferential strategies to emulate clinical trials in electronic health records (DRIAD-
EHR) data (Aim 3), with “prospective” outcomes using three big data sets: the UK-TRE with 20 year of
longitudinal records of 50M National Health Service patients, and the RPDR Database (based at Mass General
Brigham),and the Clalit database in Israel – each with 6M individuals followed for over 20 years. Each Aim has
two approaches: data-driven, hypothesis-generating analyses to discern disease-relevant drug signals; and
hypothesis-testing in which positive findings from one approach are evaluated using the other approaches to
assess rigor and reproducibility. This coordinated program compensates for the limitations of each individual
informatics approach to promote discovery and critical evaluation of “lead compounds” for known and novel AD
pathways. To execute this strategy, we have assembled a multi-site, multi-disciplinary team with expertise
ranging from clinical care to computer science and systems pharmacology. Some of the team members are AD
experts and others bring an outsider's perspective. Finally, as a deliverable, we will continue to produce open-
source data packages to release all the supporting evidence, software, and data with provenance in
accordance with FAIR (findable, accessible, interoperable and reproducible) standards through Synapse.
These data packages have lead to one clinical trial and will help to prioritize follow on clinical and translational
studies including collaborations with industry or community members at large involved in new clinical trials.

Public health relevance
Project Narrative Repurposing existing FDA-approved drugs is one approach to accelerating proof-of-concept and ultimately therapeutic clinical trials for Alzheimer's disease (AD). We propose to continue our bioinformatics campaign, parallel to a traditional drug campaign, using available expression data from AD brains in the public domain as our “laboratory” and electronic heath records (EHR) as our “clinical trial infrastructure”. Resulting data packages from these analyses will be shared on Open Science platforms and will help to prioritize follow on clinical and translational studies, which has lead to a new clinical trial.